National Center for Engagement in Diabetes Equity Research: National CEDER

Project Summary: Overall
Of the ~37 million Americans with diabetes, 90–95% have type 2 diabetes (T2D).1 T2D and diabetes
complications disproportionately impact United States (U.S.) racial and ethnic minority communities.
Additionally, populations with low socioeconomic status (SES), those living in rural areas, and low-resourced
communities bear a disproportionate burden of diabetes illness. Advancing equity in T2d disparities necessitates
addressing the social determinants of health; enhancing engagement in the research process; and trans-
disciplinary collaboration that incorporates multi-level interventions and methods of analysis, pragmatic designs
that enhance implementation and dissemination of effective strategies, and mixed-methods approaches. The
overall goal of the National Center for Engagement in Diabetes Equity Research: National CEDER is to
strengthen the engagement of communities and individuals from diverse backgrounds and sectors in T2D
research across the U.S. through a public–private partnership of the NYU Grossman School of Medicine (SoM),
UCLA SoM, Albert Einstein College of Medicine, American Diabetes Association, Health People, and Vision y
Compromiso. Our national reach is amplified through an expansive partnership of 18 academic institutions,
including schools of public health, schools of medicine, and minority-serving institutions; and 10 regional and
national community based organizations reaching diverse African American, Latinx, Asian American, Native
Hawaiian, Pacific Islander, and American Indian/Alaska Native communities. National CEDER, which comprises
three synergistic cores, including an Administrative Core, Stakeholder Engagement Studio Core, and Research
Consultation Services Core, aims to: 1. Strengthen established community-engaged, multi-sectoral regional
partnerships to create a centralized, national network infrastructure designed to foster equitable engagement in
T2D research; 2. Accelerate equitable engagement of diverse communities and sectors through a partnership
hub model and integrated SDOH and health equity frameworks that will inform T2D research priorities and
methods; 3. Use community engagement, implementation science, cultural adaptation, and intersectionality
frameworks to improve uptake of research principles, methods and engagement strategies in T2D research
through a robust studio and consultancy model rooted in bi-directional capacity building and co-leadership
between community, healthcare, municipal, and research partners; and 4. Collaborate with researchers from
diverse disciplines and multi-sector stakeholder groups to synthesize and disseminate best practices and
lessons learned in advancing equitable, sustainable, and replicable community engagement across the T2D
research spectrum. National CEDER efforts will foster community-led and -informed T2D equity research by
integrating community engagement across the research spectrum.

Public health relevance
Project Narrative: Overall The overall goal of the National Center for Engagement in Diabetes Equity Research: National CEDER is to strengthen the engagement of communities and individuals from diverse backgrounds and sectors in type 2 diabetes (T2D) research across the research spectrum and the United States. National CEDER will achieve this goal by 1) creating a centralized, national network infrastructure, 2) creating a partnership hub model that will inform T2D research priorities and methods, 3) developing a robust studio and consultancy model rooted in bi- directional capacity building and co-leadership, and 4) collaborating to disseminate best practices and lessons learned. National CEDER is an expansive partnership consisting of 18 schools of public health, schools of medicine, and minority-serving institutions; and 10 regional and national community based organizations reaching diverse African American, Latinx, Asian American, Native Hawaiian, Pacific Islander, and American Indian/Alaska Native communities, geographic areas, and communities facing historical marginalization.